Wake Forest University Vesicant Exposure Resource and Coordination Core

Project Summary – Administrative Core
Successful execution of the Vesicant ExRC relies on the establishment of a strong Administrative Core (AC) to
oversee and coordinate all operations. By leveraging the administrative expertise and resources of the Wake
Forest Institute for Regenerative Medicine (WFIRM), where most Vesicant ExRC operations will be co-located,
the AC will ensure bi-directional exchange and synergism among Facility Cores, NIH program managers, and
CCRP collaborators. The AC will be organized using program management principles developed by WFIRM
staff while managing more than $300M in large, multi-institution programs over the last decade. The AC will be
led by the Vesicant ExRC Director, who will be assisted by an Administrative Program Manager and a seasoned
administrative team already located within WFIRM. The AC will support management and research coordination
of the Vesicant ExRC via five specific aims: 1) establish business practices to guide Vesicant ExRC
programmatic and operational decisions; 2) facilitate communication among the Vesicant ExRC and NIH
leadership, CCRP-funded investigators, other ExRC facilities and stakeholders; 3) refine operating procedures
based on quality control and participant feedback; 4) establish training resources to educate the CCRP
community; and 5) develop an evidence-based transition plan to sustain CCRP function as an independent
facility. The Vesicant ExRC will be guided by a seasoned administrative team with proven expertise in managing
large, multi-institution programs involving academic and corporate participants. The implementation of proven
business practices throughout the Vesicant ExRC will support the CCRP community by accelerating exposure
operations, facilitating open and transparent practices, and establishing a sound foundation for conducting
rigorous and efficient Vesicant ExRC operations and transitioning to a self-sustaining resource after NIH support
is complete.